Evaluating the Multiscale Effects of Fentanyl-Induced Dependence and Abstinence within the Mouse Basolateral Amygdala

PROJECT SUMMARY / ABSTRACT
The United States is intensely affected by an ongoing opioid crisis. This crisis has garnered national attention
and caused the mobilization of national resources to abate the ongoing crisis. In the previous four years, the
U.S. has suffered in excess of 300,000 deaths due to overdose (OD). Over 200,000 of these deaths can be
directly attributed to fentanyl abuse. Due to the incredible potency, availability and addictive properties,
fentanyl related deaths show no signs of decelerating. Due to the persistent dysphoria and anhedonia in
abstinence, fentanyl users are at an immense 4-8 times increased risk of overdose after abstinence. This
underscores the importance and urgency by which new research needs to interrogate the substrates
predisposing relapse. Novel investigative research must be employed to better understand the mechanisms by
which fentanyl induces such dependence and what persistent changes may contribute to relapse. The
multiscale approach in this proposal aims to comprehensively evaluate the molecular, projection, and
behavioral dynamics disrupted as a result of fentanyl dependence and interrogate these dynamics into
abstinence. This approach will incorporate virally-mediated strategies, nuclear labeling, and subsequent single-
nucleus RNA sequencing to evaluate how fentanyl dependence and abstinence may differentially affect
projections in the basolateral amygdala (BLA). This approach allows for an unprecedented observation into the
molecular mechanisms by which fentanyl may differentially affect reward-seeking projections versus aversion-
inducing projections with single-cell resolution. Next, this proposal will address how fentanyl dependence and
abstinence affects rewarding and punishing experiences by combining in vivo imaging with various behaviors.
This combination enables a real-time view of the BLA as it differentially modulates independent projections
during valenced behaviors, and importantly, enables us to observe how fentanyl dependence may dysregulate
this modulation even after abstinence. This will provide molecular resolution into how fentanyl differentially
affects specific BLA projections encoding reward-seeking and avoidance behaviors; then aims to capture the
dynamics of these specific projections in vivo while animals perform valenced behaviors. This multiscale
approach facilitates a comprehensive investigation into the mechanisms underlying how fentanyl dependence
may dysregulate positive or negative reinforcement, even after abstinence. This proposal importantly evaluates
the signature fentanyl dependence imprints on the limbic system and may provide novel insights into
mechanisms predisposing relapse. The National Institute of Drug Abuse has supported innovative approaches
to elucidate and ameliorate drug dependence and relapse for over 50 years. With their support, this research
will provide a multimodal training plan as well as insights into the neurobiological underpinnings of fentanyl
abuse. This will provide comprehensive training and also facilitate the development of new therapies to abate
the opioid crisis.

Public health relevance
PROJECT NARRATIVE Fentanyl is directly responsible for over 80,000 deaths per year in the United States, significantly contributing to the opioid use disorder (OUD) public health crisis. This proposal investigates how fentanyl dependence alters amygdalar circuits and how these changes persist even during abstinence. These limbic circuits exert powerful control over behavior and understanding them is crucial for developing targeted treatments for OUD.